Influence of APOE genotypes on blood brain barrier transport of DHA by mfsd2a in Alzheimer's Disease

Over 200,000 US Veterans are suffering from Alzheimer's disease (AD) and this ﬁgure is expected to increase
dramatically in the next few decades due to a higher prevalence of traumatic brain injury (TBI) and post-
traumatic stress disorder (PTSD) that are risk factors of AD among soldiers returning from Iraq and Afghanistan
wars. The apolipoprotein E (APOE) ε4 allele is the most prevalent genetic risk factor for AD, representing 60%
of AD subjects in the general population. The apoE protein is a functional component of plasma involved in the
transport of docosahexaenoic acid (DHA) into the brain which plays a key role in neurotransmission,
membrane repair and cell signaling. Recent investigations have identiﬁed loss of DHA within
phosphatidylcholine (PC) in both the brain and blood of AD patients. Our previous work shows that pattern of
DHA alterations seen in ε4 carriers with preclinical AD is similar to those seen in ε4 carriers with TBI or TBI
+PTSD. While the brain is able to synthesize most lipids, DHA has to be acquired from the periphery since its
de novo synthesis is insufﬁcient to meet the high demand in the brain. Studies show that among ε4 carriers,
transport of DHA to the brain is reduced compared to non-ε4 carriers, contributing to the pro-inﬂammatory and
pro-amyloidogenic brain environment that is conducive to the development of AD. As such, increasing DHA
transport into the brain could be important for preventing or treating AD among ε4 carriers who are at an
exceptionally higher risk for developing AD and don't respond well to experimental AD treatments. Lyso-PC
(LPC)-DHA is specially transported to the brain through a specialized transporter major facilitator superfamily
domain containing 2A (mfsd2a) within the blood-brain-barrier (BBB). We have observed that the expression of
mfds2a is reduced in the cerebrovasculature of ε4 carriers compared to non-ε4 carriers, in humans and in a
mouse model of AD with human APOE4 gene (E4FAD). We observed that LPC-DHA levels are reduced in the
brain parenchyma of ε4 AD patients compared to ε4 controls and non-ε4 AD patients and in E4FAD compared
to E3FAD mice. We also observed an increase in matrix metalloproteinase 9 (MMP9) expression in ε4 AD
patients and in E4FAD mice. We hypothesize that MMP9 activity is elevated in the presence of ε4 which leads
to alterations of the cerebrovasculature, including reduced mfsd2a levels. This results in insufﬁcient brain entry
of LPC-DHA, inﬂammation, and exacerbated AD pathology. To address this problem, we will characterize DHA
containing PC and LPC species within the brains of AD and control subjects stratiﬁed by different APOE
genotypes and quantify corresponding changes in mfsd2a expression. Using EFAD mice, we will generate
temporal proﬁles of PC and LPC-DHA changes and corresponding mfsd2a reduction and its relationship with
AD pathology. Moreover, we will use both in vitro and in vivo approaches to determine whether the presence
of the apoE4 isoform in the absence of mfsd2a leads to a reduction of LPC-DHA and free DHA transport into
the brain and if boosting mfsd2a expression counteracts these effects. We will delve deeper into the
fundamental role of MMP9 in the transport of lipids into the brain and evaluate the impact of MMP9-directed
therapies on mfsd2a expression and LPC-DHA brain entry in AD. To this point, we have preliminary data
indicating that increasing mfsd2a in the brain cerebrovasculature increases brain LPC-DHA levels and reduces
inﬂammation in older E4FAD mice with well-established AD pathology. We ﬁnd these observations to be
extremely compelling as AD therapies have consistently failed in patients with 1) existing AD and 2) those
carrying the ε4 allele. These preliminary ﬁndings shows promise in treating both of these notoriously resistant
populations. Overall, these studies will elucidate mechanisms by which MMP9-mediated loss of mfsd2a causes
reduced uptake of DHA in the brain and, additionally, will explore therapeutic avenues to increase LPC-DHA
transport into the brain to prevent and treat AD, particularly in ε4 carriers.

Public health relevance
Over 200,000 veterans are diagnosed with dementia, of which, Alzheimer's disease (AD) is the major form. Veterans who have experienced traumatic brain injury (TBI) or post-traumatic stress disorder (PTSD) are at a higher risk of developing AD later in life, particularly those carrying the apolipoprotein E (APOE) ε4 allele. There is strong evidence that low dietary omega-3 docosahexaenoic acid (DHA) contributes to brain inflammation and amyloid burden in AD. Studies of veterans with TBI/PTSD show that those with the ε4 allele have an abnormal accumulation of a DHA form that is directly transported from blood to the brain. Individuals with an ε4 allele have deficiencies in transporting DHA to the brain. In this proposal, we will identify mechanisms of how the ε4 allele contributes to DHA transport deficiencies into the brain with the purpose of developing therapeutic strategies to enhance brain DHA levels in AD patients with the ε4 allele.